5 - The Role of Information Technology & Treatment Heterogeneity in Population Health

PROJECT SUMMARY/ABSTRACT
Project 5 – The Role of Information Technology & Treatment Heterogeneity in Population Health
This proposal seeks to better understand the underlying microeconomic drivers of physician use of information
technology (IT), with a focus on the provision of preventive care and its downstream population health impacts.
To do so, we will leverage unique, rich data on physician use of IT (at the second-by-second level) to assess
patient eligibility for preventive care, linked to traditional data sources (e.g. claims), and quasi-random variation
in incentives.
We will incorporate methods from machine learning and econometrics to i) tractably characterize use of IT
based on numerous potential patterns of use and ii) understand heterogeneity in impacts of IT using data-
driven approaches to estimation. We will be able to study the average impact of IT on the provision of
preventive care. In addition, we will use natural variation in which incentives were moved from measures of the
process of preventive care – screening for HbA1c level – to intermediate health outcomes – HbA1c levels
under control. This will allow us to assess the impact of IT on physician and patient effort on preventive care as
well as the impact on health itself. Our approach allows us to consider not only the mean impact of IT, but also
the potential sources of its heterogeneous impacts on access and adherence to preventive care. For example,
among diabetic patients, is the primary determinant of appropriate preventive screening whether the patient
visits the doctor or, conditional on visiting the doctor, whether the physician provides appropriate screening?
How do these margins for care depend on access to IT, and physician, patient, and treatment heterogeneity?
These distinctions have important implications for designing interventions and incentives to improve health
among the diabetic population – and prevention more broadly. IT also has the potential to provide targeted
individual-level information and treatment guidelines.
Enhancing the scope of IT in this way could improve the effectiveness of targeted medical treatments in
practice. However, how individuals and their doctors actually adopt IT and use it to respond to even simple
guidelines is critical in assessing how to best disseminate patient-centered information and personalized
treatment recommendations, with the primary goal of improving population health. We will identify the variance
of health outcomes induced by a range of different medical treatments, in addition to the mean treatment
impacts typically studied. We will use our results to assess the potential population health gains from IT-driven
personalized treatment recommendations, informing policies designed to best use resources to improve the
health care management and health of an aging population.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH RELEVANCE Providing timely, effective preventive health care is critical to public health, particularly for patients with chronic health conditions. Applications of information technology (IT) hold the promise to facilitate enhancements in preventive care and, thereby, to improve population health. Leveraging unique data, we will study how IT impacts physician and patient access to, and use of, preventive health care as well as individual and population health.